SEER QUALITY CONTROL ACTIVITIES

These contract costs support quality control activities for the Surveillance, Epidemiology, and End Results (SEER) Program managed by the Surveillance Research Program of the National Cancer Institute.